Probing the Mammalian piRISC Cleavage Mechanism

PROJECT SUMMARY
The germline contains the genetic information that will be passed to future generations. Therefore, maintaining
the germline genome is essential for fertility and species survival. One mechanism of germline genome
maintenance is that of the PIWI/piRNA pathway, in which small RNAs known as piRNAs interact with a PIWI
Argonaute protein to form what is known as a piRNA-Induced Silencing Complex (piRISC). Through its
endonuclease activity, piRISC silences repetitive elements (i.e., transposons) to protect the genome for future
generations and regulates gene expression to ensure proper germ cell development and function. Loss of PIWI
function leads to infertility in at least one sex in many animals, including human males. Recent work has revealed
that the small zinc-finger protein, gametocyte-specific factor 1 (GTSF1), accelerates piRISC target cleavage.
Loss of GTSF1 function in mice and human males leads to infertility. Preliminary kinetic evidence suggests that
GTSF1 is not required for target binding or target release. However, the piRISC catalytic states associated with
GTSF1 binding have not been explored. Seven GTSF1 residues have been identified as key for target cleavage,
but most of these amino acids are not conserved in the other mouse GTSF paralogs, GTSF1L and GTSF2, even
though they also accelerate piRISC target cleavage. This proposal seeks to test the hypothesis that mammalian
GTSF proteins stabilize a catalytically active state of piRISC via key contacts with both the piRNA-target RNA
duplex and PIWI protein. Aim 1 will use single-molecule FRET to probe piRISC conformational changes in the
absence and presence of GTSF proteins to determine which, if any, catalytic state is stabilized in the presence
of GTSF. Aim 2 will employ a high-throughput screening method to identify all amino acid positions across GTSF
paralogs which are required to interact with piRISC. This study will provide insights into how GTSF1 accelerates
piRISC target cleavage and determine which GTSF residues are key for its function, providing insight into why
some human GTSF1 mutations lead to infertility. The proposed research will provide training in microscopy, in
vitro biochemistry, and bioinformatics to prepare the fellow for a postdoc studying epigenetic inheritance and a
future career as an independent investigator.

Public health relevance
PROJECT NARRATIVE For species to pass their genetic information to the next generation, the germline genome must be protected. This proposal seeks to understand how a small RNA-silencing pathway maintains the germline genome and ensures reproductive health.